Estimation of risk associated with zoonotic tuberculosis in South India

PROJECT SUMMARY
Tuberculosis (TB) in humans results from infection with members of the Mycobacterium tuberculosis complex
(MTBC). The disease is endemic in many parts of the world. So is bovine tuberculosis (bTB) - a well-recognized
zoonotic disease of bovine species (cattle and buffalo) also caused by infection with members of the MTBC.
India has the world’s highest TB burden in humans, with more than 2M new cases and 400,000 TB-related
deaths each year. India also hosts the largest bovine herd on the planet (~300M animals), and our recent studies
suggest that more than 22M of those animals may suffer from bTB. Yet the risk of zoonotic TB (zTB) resulting
from transmission of MTBC from bovines to humans in India and other high-TB burden settings is unknown. This
is a major knowledge gap, and elimination of TB will be considerably more difficult if there is spillover from a
domestic livestock reservoir to humans. This is of particular concern in countries such as India where the
frequent consumption of unpasteurized milk and close contact with infected animals likely present additional
elevated risks for zoonotic transmission. Because of this, the World Health Organization (WHO) and other
supranational organizations have developed a "Roadmap for zoonotic TB" that calls for the establishment of a
stronger evidence base to improve understanding of the burden and risk pathways of zTB to guide an effective
response. To fill these knowledge gaps, we propose studies with the overall objective of estimating the risk
associated with zTB in a high-TB-burden setting. We will accomplish this by applying rigorous quantitative risk
assessment augmented by state-of-the-art whole-genome sequence (WGS)-based molecular epidemiology
and multi-host transmission modeling. Performed at well-established study sites in Vellore and Tiruvallur districts
in Tamil Nadu, India, our Specific Aims are to: 1) Estimate the risk of human TB associated with exposure to
cattle, buffalo, or the consumption of raw milk in ~1,750 human cases and ~3,500 controls; 2) Apply WGS-based
approaches to define the genetic diversity and molecular epidemiology and perform phylodynamic and
phylogeographic analysis of MTBC lineages circulating in human TB cases, sympatric cattle and buffalo, and
locally sourced raw milk; and 3) Perform multi-host transmission modeling to quantitatively assess zTB risk to
humans and the potential benefits of control. These studies involve the application of innovative and powerful
nested case-control epidemiological surveys with WGS-based genotyping and mathematical modeling. The
results of our studies will inform and refine estimates of zTB risk, enable identification of transmission chains at
a local scale, and transform our understanding of spillover and circulation of MTBC strains between human and
bovine hosts. In the long-term, our findings will provide sustained positive impact through the development of
evidence-based approaches to quantify and reduce risk of zTB in support of the global efforts to end TB.

Public health relevance
PROJECT NARRATIVE Tuberculosis (TB) is a major public health threat that spreads readily among humans or from animals to humans (termed zoonotic tuberculosis or zTB). Yet we lack accurate estimates of zTB risk, especially in high-TB-burden settings where the disease is endemic in both humans and livestock and where there are greater opportunities for transmission of zTB from animals to humans. Our innovative, rigorously designed, and first-of-its-kind study will fill this major knowledge gap by assessing the risks associated with zTB, and thereby enable the development of evidence-based approaches to reduce spillover from livestock to humans.